ANALYTICAL PROTEIN PROFILING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Analytical Chemistry/Protein Profiling Core Core Leaders: Michael Powell, Winston Thompson, Daniel Von Deutsch Working Group: Drs. Michael Powell, Winston Thompson, Gale Newman, Rigobert Lapu, Dan von Deutsch, Jacqueline Hibbert, Xuebiao Yao